RESEARCH IMPETUS IN THE BIOMEDICAL SCIENCES

The long-term overall objectives of the MBRS Program at Clark Atlanta University dubbed, "CAU-RIBS" for Clark Atlanta University Research Impetus in the Biomedical Sciences Program, are to enhance on-going faculty research capabilities, encourage and augment efforts of new faculty in developing biomedical research programs, fostering a productive research environment. This exemplary atmosphere of research and scholarship provides a model wherein inculcated undergraduate and graduate students can acquire incentives for inquiry in the biomedical sciences. Two important accomplishments are expected to result: 1) The level of scientific productivity will increase at the University and 2) the pool of minority scientists will conspicuously increase. This proposed program emphasizes the interdisciplinary approach to biomedical research problems and consequently includes investigators from the departments of biological sciences, chemistry and physics. Clark Atlanta University, as a newly consolidated institution, views the MBRS Program's support of the individual investigator's research efforts as, a priori, providing the opportunities for them to increase their competitive skills for entrance into the general pool efforts, i.e., R-01 type competition.